TR&D1: Engineering artificial Antigen Presenting Cells, aAPC, for Adoptive Immunotherapy

TR&D 1 Summary:
Adoptive cellular immunotherapy is a cancer treatment. In adoptive immunotherapy, T cells are isolated,
manipulated, and stimulated in vitro, followed by expansion and administration into patients. Interest in this
treatment is driven by impressive Phase I clinical trial results, in which the treatment has regressed large
lesions, including treatment-resistant melanomas. The cost and complexity of treatment with adoptive
immunotherapy have limited its use to research settings. In particular, T cell expansion requires prolonged
culture. Autologous antigen presenting cells, or feeder cells, are a complex biologic that must be repeatedly
assessed for safety and reliability, further increasing cost and labor. Immunotherapeutic strategies would
benefit from effective “off-the-shelf” expansion platforms that reduce complexity and expense. In this TR&D we
will engineer and optimize nanoscale artificial Antigen Presenting Cells, nano-aAPCs coupled to simplify,
streamline, and scale-up production of T cells for adoptive immunotherapy. Our proposed studies will improve
production of highly efficacious tumor antigen-specific CD8+ and CD4+ T cells for ACT by effectively
increasing the frequency of antigen-specific cells and their functionality due to increased control of stimulating
signals.

Public health relevance
TR&D 1 Narrative Not Applicable.